BMT Core - MSK

PROJECT SUMMARY/ABSTRACT
The mission of the Blood and Marrow Transplant Clinical Trials Network (BMT CTN) is to “evaluate promising
therapeutic approaches in multi-institutional clinical trials to improve the outcomes of blood and bone marrow
transplantation and other cellular therapies for patients facing life-threatening blood disorders.” Memorial Sloan
Kettering Cancer Center (MSK) is an NCl-designated Comprehensive Cancer Center with one of the largest
BMT programs in the country. The BMT program at MSK, founded in 1973 and divided into pediatric and adult
services, is a FACT-accredited program for both hematopoietic cell transplant (HCT) and immune effector cell
(IEC) therapy. MSK has been a Core Clinical Center (CCC) of the BMT CTN since its inception. Dr. Perales
(Service Chief, Adult BMT; PI, MSK BMT CTN), Dr. Giralt (Deputy Head, Division of Hematologic Oncology; Co-
I), Dr. Boelens (Service Chief, Pediatric BMT and Cell Therapy; Co-I), and all members of the Adult and Pediatric
BMT and Cellular Therapy Services consider participation in the BMT CTN an integral part of their mission. In
this proposal, we detail our ongoing commitment to the success of the Network through an oversight structure
that includes a BMT CTN MSK Executive Committee, a BMT CTN Protocol Management Team, and a BMT CTN
Internal Advisory Board, which leverage senior leadership of the Division of Hematologic Oncology and Pediatric
BMT Service as well as outstanding scientists and investigators at MSK. As part of our continued commitment
to Network leadership, we propose a multicenter phase II clinical trial in adults and children with severe sickle
cell disease (SCD), in which we will evaluate a pharmacologic immunosuppressive strategy prior to reduced
toxicity myeloablative mismatched unrelated (MMUD) HCT, using post-transplant cyclophosphamide (PTCY)-
based graft-versus-host disease (GvHD) prophylaxis. The trial will employ a novel platform to mitigate the risk of
graft failure in a patient population at high risk for allograft rejection and treatment-related complications, as well
as pharmacokinetic-based models to guide individualized dosing of fludarabine, busulfan, and rabbit ATG for
optimal drug exposure. We propose 3 specific aims: (1) Demonstrate MSK has the clinical and translational
expertise, novel cell and gene therapy capabilities, and early- and late-phase trial experience to fulfill the
obligations of a BMT CTN CCC and advance the Network’s mission and goals; (2) Complete a phase II study in
which patients with severe SCD will receive an HCT from an MMUD donor with PTCY-based GvHD prophylaxis
(the primary endpoint will be to estimate primary graft failure at 1-year post-HCT); and (3) Describe how MSK’s
operational and scientific approaches to conducting HCT trials will support the mission and activities of the BMT
CTN. The proposed study is highly relevant to the BMT CTN, as it addresses an unmet need for a well-tolerated
alternative donor platform with stable engraftment in patients with SCD, and is in line with the goal of the BMT
CTN to prioritize clinical studies that advance HCT approaches for non-malignant blood diseases.

Public health relevance
PROJECT NARRATIVE Sickle cell disease (SCD), which arises from a missense mutation in the β-globin gene that causes polymerization of sickle hemoglobin (HbS), affects approximately 100,000 individuals in the United States and is associated with shortened life expectancy, with only 50% of patients surviving beyond their fifth decade. The use of hydroxyurea, newer second-line therapies, and chronic blood transfusion may alleviate some of the complications of SCD, but allogeneic hematopoietic cell transplantation (HCT) using a matched related donor is the only potential cure and is considered standard of care for patients with severe SCD. The proposed phase II clinical trial in adults and children with severe SCD will evaluate a pharmacologic immunosuppressive strategy prior to reduced toxicity myeloablative mismatched unrelated donor (MMUD) HCT, followed by post-transplant cyclophosphamide (PTCY)-based graft-versus-host disease (GvHD) prophylaxis, in order to mitigate risk of graft failure in a patient population at high risk for allograft rejection and treatment-related complications.